Protocol Review and Monitoring System

All Virginia Commonwealth University (VCU) cancer-related clinical research is subject to initial and ongoing review for scientific merit and scientific progress by the VCU Massey Cancer Center (MCC). The MCC has the authority to initiate and terminate all such research and to establish priorities among studies potentially competing for MCC resources or patients. This authority is exercised by the Protocol Review and Monitoring Committee (PRMC).

Public health relevance
The Protocol Review and Monitoring Committee is responsible for ensuring that all MCC clinical trials have scientific merit and that they make scientific progress once open. The committee also prioritizes clinical trials that potentially compete for the same patients or resources.